Role of Long Non-Coding RNAs in Exosome Biogenesis

SUMMARY
Exosomes are nano-sized vesicles secreted into the extracellular milieu by all cells in physiological and
pathological states. Exosomes can effectively mediate cell-cell communications, deliver macromolecules such
as proteins and nucleic acids to cells, and induce functional changes in recipient cells. Recent studies have
implicated that exosomes participate in a broad range of pathophysiological processes, including immune
regulation, organogenesis, and carcinogenesis. Despite great interest in exosomes for both diagnostics and
therapeutics applications, the basic understanding of the regulation of exosome secretion is not well established.
Long noncoding RNAs (lncRNAs), defined as RNAs longer than 200nt without functional protein-coding capacity,
are emerging as regulators of gene expression and cellular functions. Our preliminary data has shown that
lncRNAs play regulatory roles in exosome biogenesis in both physiologic and cellular stress conditions, such as
hypoxia and oxidative stress. How the biogenesis, intracellular trafficking, and cargo soring of the exosomes are
regulated by lncRNAs is largely unknown. This project will investigate the role of cytoplasmic and nuclear
lncRNAs in exosome biogenesis and identify how they function in the docking, cargo sorting, and fusion of late
endosomes or multivesicular bodies to the plasma membrane.
The role of lncRNA in the regulation of signaling pathways and genes that regulate different aspects of exosome
biogenesis and exosome cargo selection will also be characterized. We will investigate how cellular stress
pathways, such as the HIF1-alpha and MAPK pathways, through lncRNA or independent of the lncRNAs,
influence exosome biogenesis and cargo selection.
Research accomplishments from this project will deepen our understanding of the basic biology of regulation of
exosome biogenesis and open new avenues for the therapeutic use of exosomes and lncRNAs in the treatment
of various diseases. Exosomes play a vital role in many biological processes, including adaptive immune
function, cancer metastasis, the development and differentiation of stem cells, tissue regeneration, and viral
replication. They also exhibit profiles specific to the cell of origin and therefore represent novel biomarkers that
show promise for improving disease diagnosis. Their central role in cell-to-cell communication presents
opportunities for the development of improved therapeutics. Therefore, it is essential to understand the role of
lncRNAs in regulating exosome production and release in order to realize these diagnostic and therapeutic
opportunities.

Public health relevance
Project Narrative Exosomes are nano-sized vesicles produced by all cells in both physiological and pathological states that play a vital role in multiple biological processes including cell-cell communication, immune regulation, tissue development and regeneration, and cancer metastasis. Exosomes represent excellent candidates for the development of new diagnostic and therapeutic tools, yet the mechanism controlling their biogenesis is poorly understood. In this Project, we will study the role of long non-coding RNA (a novel class of gene expression regulators) on exosome biogenesis, thereby advancing our understanding of these mechanisms and providing the basis for the use of exosomes as novel biomarkers and the development of new therapeutics.